Pan-cancer genomic characterization of human papillomavirus associated tumors

PROJECT SUMMARY/ABSTRACT
Human papilloma virus (HPV) infection causes an estimated 610,000 human cancers globally every year. HPV
accounts for nearly all cervical and anal squamous cell carcinomas, increasing rates of head and neck squamous
cell carcinomas, and a subset of other anogenital squamous carcinomas – all with relatively heterogenous clinical
outcomes due to a lack of personalized care. My goal is to use a pan-cancer cohort of patients to define the
molecular heterogeneity shared across HPV-associated anatomic sites. Analyses that integrate many
genomic variables across patient cohorts, powered by next-generation sequencing, have successfully
ascertained genomic perturbations in individual tumor types. However, few studies have focused particularly
on genomic changes across HPV(+) cancers of differing anatomical origin. Additionally, there is little
genomic data available to analyze these differences in anogenital cancers. While large scale collaborative efforts
to investigate the molecular landscape of head and neck cancers have been successful, the specific genomic
changes and clinical outcomes attributable to HPV infection lack clarity due to smaller HPV(+) cohorts and
confounders like smoking. The HPV lifecycle is tightly linked to differentiation of the epithelial cells it infects. The
transformative potential of the oncogenic strains is classically attributed to expression of viral oncoproteins E6
and E7, which subsequently inactivate tumor suppressors TP53 and RB, respectively. However, while persistent
infection with high-risk HPV types and expression of E6/E7 proteins are capable of cellular immortalization in
vitro and are necessary in the formation of tumors, these events alone are insufficient for cancer development
in vivo. Thus, viral and host genomic changes must occur alongside HPV infection. It is my hypothesis that
the molecular heterogeneity of HPV-associated tumors is shared across anatomic sites and can be used
to subclassify these cancers based on therapeutically meaningful pathways. To test this, integrative
analyses of HPV(+) and HPV(-) tumors will be employed using hybrid-capture sequencing across extensive
cohorts of cervical, oral, and anogenital tumors. Specifically, paired-end DNA sequencing using probes specific
to hundreds of genes commonly involved in cancer will be used to identify potential driver somatic mutations and
copy number alterations in these tumors (Aim I). Novel genomic changes determined here will then be examined
in context with other known biologically pathways and molecular perturbations in HPV-associated cancers. Next,
probes specific to the HPV genome will be used to assess viral properties such as strain, viral load, and
integration events within and across tumor types (Aim II). Finally, the prognostic effect of oncogenic PIK3CA
alterations will be determined through integration of clinical variables and overall survival using multivariate
modeling (Aim III). This unique training opportunity and exemplary mentoring environment will ensure my
complete development as a physician-scientist in clinical genomics working to identify novel means of
subclassifying patients in order to tailor treatments and improve outcomes.

Public health relevance
PROJECT NARRATIVE Human papilloma virus (HPV) infection accounts for nearly all cervical and anal squamous cell carcinomas, a subset of other anogenital squamous carcinomas, and increasing rates of head and neck squamous cell carcinomas – all with relatively heterogenous clinical outcomes due to a lack of personalized care. Here, I propose a pan-cancer genomic analysis using extensive patient cohorts and targeted sequencing techniques to investigate the heterogeneity surrounding HPV-associated cervical, oral, and anogenital cancers as an ideal project to train as a future physician-scientist with an exceptional sponsor and complementary teams to support my research and clinical training. Through completion of this project, I will demonstrate that patients can be stratified in the clinic beyond anatomy and cytopathology, accommodate treatments to individuals, and work to improve patient outcomes through personalized medicine.